Ventral pallidal transcriptional adaptations underlying punishment-resistant opioid intake

PROJECT SUMMARY
Opioid use disorder (OUD) is an escalating public health concern that has resulted in over 570,000 overdose
deaths between 1999 and 2020. Exposure to prescription opioids (such as oxycodone) is frequently an
initiating factor in OUD, with 9.9 million people reporting misusing prescription opioids annually (Centers for
Disease Control). While many individuals can use opioids as prescribed, a subset of individuals transition to
problematic drug use, which is defined as continued drug intake despite negative consequences and is a
hallmark feature of OUD. These individual differences have been modeled in rodents: most subjects will readily
self-administer opioids but will suppress drug intake when drug seeking is paired with punishment such as a
foot shock (punishment-sensitive). Conversely, ~20-30% of individuals will persist in drug seeking despite this
punishment (punishment-resistant). Elucidating the neural mechanisms underlying individual differences
in punishment-resistant drug seeking is critical for understanding susceptibility to compulsive drug
use in OUD. The ventral pallidum (VP) has emerged as a central brain area for encoding the relative value
and motivation for rewards and translating this motivation into action. Recent work has also established that
VP activity is necessary for drug seeking and relapse, and critically modulates reward seeking under conflict.
The VP is an incredibly heterogeneous nucleus, with distinct neurochemically- and anatomically-defined
populations playing discrete and dissociable roles in behavior. However, our understanding of how the VP
subpopulations work in concert to orchestrate motivated behavior in the context of OUD is severely limited by
the inability to identify functionally-relevant VP populations. Here we will use state-of-the-art omics platform to
obtain high resolution cellular information of comprehensive cell types in the VP and their role in OUD. Our
long-term goal is to elucidate the molecular and neural circuit basis of punishment-resistant opioid self-
administration, and to leverage this understanding to develop targeted therapies to prevent or reverse the
transition to punishment-resistant opioid intake in patients with OUD. The outcomes of this proposal will lay the
foundation for this goal by creating a comprehensive cellular atlas of the VP and characterizing transcriptional
adaptations induced by self-administration of oxycodone (Aim 1), and by profiling ensembles of VP neurons
that are activated in the context of oxycodone self-administration (Aim 2). By profiling transcription factor
binding using cutting edge “calling card” technology, we will establish whether transcriptional profiles
distinguishing punishment sensitive- and resistant- individuals emerge with repeated self-administration, or
whether these differences are antecedent to opioid exposure and only revealed upon introduction of
punishment (Aim 3). This work will help inform future therapies for OUD and will identify molecules capable of
modulating functionally-relevant ensembles of VP neurons as a therapeutic strategy for OUD.

Public health relevance
PROJECT NARRATIVE A hallmark symptom of opioid use disorder is compulsive drug use, defined as drug intake despite negative consequences. We will elucidate how opioid self-administration induces transcriptional adaptations within the ventral pallidum with single-cell resolution, and how adaptations within functional ensembles of ventral pallidal neurons predict the development of compulsive opioid intake in a subset of individuals. This insight will be critical for understanding individual variability in susceptibility to prescription opioid abuse and for preventing or reversing the transition to compulsive drug intake in opioid use disorder.